Investigating financial wellbeing, biological aging, and risk of Alzheimers disease and related dementias in a life course synthetic cohort

Project Summary/Abstract
The number of Americans aged 65+ living with Alzheimer’s disease and related dementias (ADRD) is
projected to double in the next 30-40 years, particularly for minoritized groups, widening existing
disparities in ADRD. Poor financial wellbeing is a major source of stress, and the cumulative impacts
of financial strain may harm cognition. Life course experiences of financial strain are common,
especially for adults from minoritized groups (e.g., Black Americans) who often also face greater ADRD
burden. Given the pervasiveness of life course financial stressors in the U.S. and growing financial
disparities for groups inequitably burdened by ADRD, there is a critical need to examine how and when
poor financial wellbeing harms cognition and contributes to ADRD risk and disparities over the life
course. The central hypothesis of this application is that poor financial wellbeing across the life course,
particularly starting in early life, increases risk of cognitive decline and ADRD. Stress likely plays a role,
as financial hardship causes stress which may accelerate biological aging and, in turn, lead to cognitive
decline. Interventions to improve financial wellbeing would likely reduce ADRD burden, but what such
interventions should be and when they should occur is unclear. Previous research has lacked the
longitudinal data ideally suited to answer these questions. Leveraging three datasets that, together,
span the life course, the scientific objective of this study is to (Aim 1) build a synthetic cohort to examine
(Aim 2) the life course relationship between financial wellbeing and ADRD outcomes and disparities,
(Aim 3) its potential mechanism via biological aging, and (Aim 4) the components and timing of
hypothetical interventions to reduce ADRD burden and disparities associated with poor financial
wellbeing. The proposed work will use data from the National Longitudinal Study of Adolescent to Adult
Health (ages: 12-43), Coronary Artery Risk Development in Young Adults (ages: 18-60), and the Health
and Retirement Study (ages: 50-100+). The research addresses NIA strategic directions to better
understand social determinants of ADRD across the life span and their mechanisms. Understanding
how and when financial wellbeing most impacts cognition could inform actionable strategies to reduce
ADRD burden, especially among financially disadvantaged groups. Complementing this research plan
is a training plan that builds on the applicant’s background and prior training in life course epidemiology
and foundational causal inference theory and includes new training in 1) applied data fusion and
advanced causal inference techniques, 2) financial wellbeing and social policy, 3) neuroscience and
measurement of ADRD, and 4) biological aging. The strong mentorship team and research and training
plans will prepare the applicant for a successful independent research career investigating the life
course timing and pathways via which socioeconomic stressors harm cognition and impact ADRD risk.

Public health relevance
Project Narrative Alzheimer’s disease and related dementias (ADRD) are a major and growing public health concern, but their life course social determinants have been difficult to study because most studies lack data on the full life span. This project will build a synthetic cohort from three component datasets that, together, cover the full life course to investigate the life course impact of financial wellbeing on later cognitive decline, ADRD risk, and disparities in these outcomes. In addition, we will examine whether accelerated biological aging acts as a mechanism through which these relationships operate and identify hypothetical age-specific interventions on financial wellbeing that could reduce ADRD burden and disparities.